Administrative Core

ADMINISTRATIVE CORE: PROJECT SUMMARY/ABSTRACT
The overarching goal of the Administrative Core is to provide the administrative support, communication and
coordination necessary for accomplishing the goals of our multidisciplinary Autism Center of Excellence (ACE).
The Administrative Core will be led by Drs. Joachim Hallmayer and Ruth O’Hara with dedicated support from an
administrative support team. Services provided by the Administrative Core to the Projects and Cores include: 1)
Communication across all 4 Projects and 4 Cores, with the External Advisory Committee, and the ACE Steering
Committee, including scheduling of all meetings, within and across Cores and Projects, with consultants,
collaborators, and the External Advisory Committee; 2) Management of Institutional Review Board (IRB)
protocols for all Cores and Projects; 3) Implementation of Procedures for Conflict Resolution; 4) Sharing of data
in accordance with NIH Grants Policies; and 5) Maintenance of the ACE website. The Administrative Core will
provide scientific oversight for the conduct and integration of our cross-disciplinary research among the ACE
investigators, their Projects and Cores, the External Advisory Committee, the ACE Steering Committee, and with
collaborative investigators and organizations outside the program. We will implement a within- and cross-project
publication plan to ensure that data are being analyzed, written-up and submitted for review and published in a
timely fashion. Another important responsibility of the Administrative Core is to oversee the financial
management of ACE funds. Finally, the Admirative Core will provide administrative oversight of involvement of
trainees in our ACE. In sum, the Administrative Core will provide fully integrated administrative services to all
Projects and Cores for the management, communications, coordination, and financial administration of our
Center. All efforts of the Administrative Core align to support the Center in advancing our understanding of the
interactions between sleep and ASD.